PREDICT (Precision Medicine, Education, Data Informatics and Community Translation) Institute

ABSTRACT
Xavier University of Louisiana seeks support from the NIH National Institute on Minority Health and Health Disparities to complement the research infrastructure in the College of Pharmacy through a new initiative. The proposed initiative will establish the Precision Medicine, Education, Data Informatics, and Community Translation (PREDICT) Institute, a comprehensive programmatic initiative creating a holistic and replicable framework for the utilization of electronic health data and community translation to affect the decision-making process to improve health outcomes. The Institute will extend the technical research exchange (TREX) program at Xavier to include training of current and future researchers on health informatics best practices. The use of population health and bioinformatics data are potential tools useful in collective approaches required to achieve health equity. The Specific Aims of the PREDICT Institute are: Specific Aim #1: To enhance the existing Xavier health informatics infrastructure by increasing capacity for data acquisition, data warehousing, data access, data analytics, and technical assistance necessary for addressing health outcomes in underserved communities. Specific Aim #2: To strengthen the research and outreach infrastructure of the university to promote community-engaged translational/clinical research and health promotion to mitigate health disparities.

Public health relevance
The purpose of the Precision Medicine, Education, Data Informatics, and Community Translation (PREDICT) Institute is to serve as a holistic and replicable framework for the utilization of electronic health data and community translation to affect the decision-making process to improve health outcomes. The PREDICT Institute will extend the technical research exchange (TREX) program at Xavier to include training of current and future researchers on health informatics best practices. The use of population health and bioinformatics data will demonstrate their value as useful tools in collective approaches required to achieve health equity.